ASCB's MOSAIC Program (AMP)

Project Summary/Abstract
Scientists who are women, disabled or certain racial minorities remain under-represented among the tenure-
track faculty at US research universities. Broadening participation by researchers from these under-represented
groups (URGs) is a priority, because it will enhance science innovation and productivity, improve future trainees’
learning environments and enhance the international competitiveness of the US biomedical enterprise. Recent
studies have shown that the postdoc-to-faculty transition is a major attrition point for scientists from URGs on
the path to tenure. Therefore, new interventions are needed to support researchers from URGs as they seek
and commence tenure-track positions at research-intensive universities.
The American Society for Cell Biology (ASCB) is well-positioned to address this need. ASCB has a
successful, decades-long history of promoting the research and professional development of scientists from
URGs at all career stages. Building on this deep experience and the rich resources of ASCB membership, we
propose an ASCB MOSAIC Program (AMP) to enhance the success of scholars from URGs in tenure-track
faculty positions. AMP adopts the tripartite integration model of social influence, an established framework
postulating that trainees’ senses of science efficacy, science identity and alignment of values contribute to their
persistence in STEM fields. AMP will provide a combination of evidence-based, rigorously evaluated skills
development workshops, mentor training and institutional culture-change initiatives to augment AMP scholars’
science efficacy, identity and values alignment. We will accomplish this goal through three Specific Aims:
Specific Aim 1: To provide skills development for AMP scholars. We will create a cohort-based
professional skills development program that builds on the strengths of AMP scholars to enhance their
preparation, hiring, retention and success in tenure-track, research-intensive faculty positions.
Specific Aim 2: To train AMP program mentors. We will create a cohort-based training program for AMP
scholars’ postdoctoral supervisors, plus additional, supplemental scientific and professional development
mentors, with these relationships continuing across the postdoc-to-faculty transition.
Specific Aim 3: To catalyze institutional interventions that broaden participation among research
faculty. We will convene departmental and university leadership to exchange best practices for effecting
institutional change, improving their cultures of inclusiveness and broadening participation, retention and
success among faculty from URGs.
We expect that AMP will significantly enhance our scholars’ success as tenure-track research faculty. Our
mentor training and institutional change initiatives will also benefit additional trainees and universities, beyond
our direct participants, extending AMP’s impact across the nation. We anticipate that the successful completion
of AMP will meaningfully advance inclusive excellence across the US academic biomedical workforce.

Public health relevance
Project Narrative The demographics of tenure-track biomedical faculty at research universities do not closely match those of the general US population, as women, some racial groups and disabled scientists are under-represented in the professoriate. Broadening participation by these groups is a national priority because it will ensure that the US captures as much of the research talent pool as possible and because it will make universities more equitable. To address this need, the American Society for Cell Biology’s AMP program will combine skills development workshops, mentor training and institutional culture-change initiatives at universities to support postdoctoral researchers from under-represented groups as they attain and thrive in tenure-track faculty positions.